Function of NF2/Merlin in regulation of the Hippo/Salvador/Warts growth control pathway

Project Summary/Abstract
Neurofibromatosis type 2 (NF2), a human disease characterized by the formation of bilateral vestibular
Schwannomas (resulting in deafness) and other tumors, is caused by loss of the tumor suppressor
protein Merlin. Studies using the fruit fly Drosophila and subsequently confirmed in mammalian systems
indicate that Merlin is an upstream component of the Hippo pathway, a conserved signal transduction
pathway that regulates tissue growth. Mutations in Merlin and other Hippo pathway components are
believed to cause tumors because they cause activation of an oncogenic protein Yorkie/YAP and
increased expression of growth promoting genes. Identifying specific proteins and signal transduction
pathways with which Merlin interacts is especially important because these partners may act as genetic
modifiers of NF2 disease phenotypes and provide potential targets for therapeutic agents.
We seek to understand how Merlin and the other HSW components are organized into a signaling
complex at the cell cortex and how the activity of this complex is controlled. We have shown that Merlin
and its binding partner Kibra nucleate formation of a signaling complex at a site separate from
intercellular junctions, and thus that these proteins can function in parallel to another upstream
regulator, Expanded. We also have shown that as these proteins assemble a signaling complex, they
recruit an E3-ligase complex that degrades Kibra and represses signaling in a negative feedback loop.
In the next funding period, we propose that Kibra degradation is promoted by mechanical tension and
that this is one mechanism by which tension controls tissue growth. We also plan to test a model we
propose in which Kibra and Merlin are recruited to the junctional cortex in an inactive state by the apical
polarity protein aPKC in opposition to medial actomyosin networks which facilitate medial accumulation
and activation of these proteins. To explore these novel hypotheses, we have developed tools and
techniques that allow us to examine the localization and dynamics of Hippo pathway proteins
expressed at endogenous levels in living tissues. Using with the exquisite genetic tools available in
Drosophila, we can now elucidate the role of each pathway component in assembling and activating the
Hippo pathway. These experiments are expected to provide insights into NF2, tumor suppression in
general, and the role of actomyosin dynamics in regulating signaling processes. Finally, these studies
should contribute to work on the mechanisms by which cellular interactions function to control tissue
growth and determine cell fate during development and regeneration.

Public health relevance
Project Narrative Neurofibromatosis type 2 (NF2) is caused by loss of the tumor suppressor protein Merlin. Studies initiated using the fruit fly Drosophila and subsequently confirmed in mammals indicate that Merlin is part of a cellular mechanism, called the Hippo signaling pathway that regulates tissue growth during development. Our goal is to use the powerful genetic and cell biological tools available for Drosophila research to understand how Merlin functions to regulate the Hippo pathway so that we can understand what goes wrong in the NF2 disease, information which ultimately can be used to develop therapies to treat NF2 patients.